Nanospray treatment of biofilm infections in wounds

PROJECT SUMMARY/ABSTRACT
Microbial biofilm infections are a leading complication in healing of wounds arising in a multitude of settings,
including severe burns, non-healing pressure ulcers, dog bites, surgical site infections, and gunshot wounds.
Infection impairs the wound healing process and is associated with substantial morbidity and mortality. A recent
meta-analysis indicates that the prevalence of biofilms in chronic non-healing wounds is 78% [1]. Biofilm
formation imparts resistance to antibiotics through innate resistance factors including the drug diffusion barrier
of the biofilm's extracellular polymeric substances (EPS) and through induced changes in gene expression, cell
signaling and metabolism. Significant correlations have been demonstrated between biofilm formation and
multi-drug resistance (MDR) in diverse clinical isolates from wounds [2]. An additional complication is that
biofilm formation and progression are not visible to the naked eye; as a result, biofilm infections are not
discerned until they are well established and recalcitrant to treatment.
A key barrier to identification and treatment of biofilm infections is penetration of their EPS in order for an
imaging contrast agent or therapeutic to reach the infecting bacteria. Penetration of biofilms by surfactants,
primarily through detergency and surface energy modifications that inhibit bacterial adhesion, may offer a
solution to this problem. Strong surfactants such as Tween 20 and Triton X-100 have been shown to disperse
biofilms but are too cytotoxic for systemic clinical applications. Polymeric surfactants such as poly(acrylic acid)
polyelectrolyte, Carbopol 934TM, and poly(alkylene oxide), Poloxamer 407TM, inhibit biofilm formation but are
non-specific and are not strongly antimicrobial [3].
We have recently developed novel graft polyelectrolyte surfactants (PS) that combine the functionalities of these
previously used materials with the ability to encapsulate into nanoparticles and deliver cationic antimicrobials
(CAMs), with the result being enhanced activity against biofilms in vitro. We propose that such PS can be
employed in the wound infection environment, both for imaging and for treatment, by formulation into a
“nanospray” that is able to achieve broad coverage within the wound bed, avoid rapid clearance of dyes or of
active CAMs in the highly active regenerating wound environment, and penetrate biofilm barriers via the
polyelectrolyte surfactant detergency. In order to test this hypothesis, we will: (1) expand the repertoire of CAMs
that can achieve favorable nanoformulation with the PS; (2) evaluate the ability of nanospray PS-CAM
formulations to treat biofilms in vitro and in vivo; and (3) develop and evaluate the ability of PS-CAM-ICG (where
ICG = indocyanine green) formulations to image biofilm formation.

Public health relevance
PROJECT NARRATIVE Microbial biofilm infections are a leading complication in healing of wounds arising in a multitude of settings, including severe burns, non-healing pressure ulcers, dog bites, surgical site infections, and gunshot wounds; the physical barrier of the biofilm makes it recalcitrant to traditional antibiotic treatment. A potential solution that shows activity against biofilms in vitro is the use of novel graft polyelectrolyte surfactants (PS) with the ability to encapsulate into nanoparticles and deliver cationic antimicrobial peptides (CAMs) across the biofilm barrier. In the proposed work, PS-CAM nanoparticles will be deployed in the wound infection environment, both for imaging and for treatment, by formulation into a “nanospray” that is able to achieve broad coverage within the wound bed, avoid rapid clearance of dyes or of active CAMs in the highly active regenerating wound environment, and penetrate biofilm barriers via the polyelectrolyte surfactant detergency.